Modeling and dynamics of biomolecules on cellular scales

The main goal of the proposed research is to understand how cellular environments
impact biomolecular structure, dynamics, and function. More specifically, emphasis will
be placed on understanding enzyme function in the cellular context, interactions of cellular
environments with membranes, and the interaction\ of liquid-liquid phase separated
condensates with cytoplasmic environments. The research will employ computational
tools for modeling and simulations of biomolecular systems. Multiscale modeling and
novel machine learning tools will be developed to complement and enhance traditional
computational approaches so that the biological questions can be addressed more
efficiently. Connections to experiment will be made via collaboration. The insights gained
from this work will increase our fundamental understanding of biological function and
disease at the molecular level under consideration of cellular environments. Based on
these insights, it is expected that it will become possible to develop rational drug design
protocols targeting a variety of diseases that fully consider the cellular context.

Public health relevance
Most biological function takes place inside cells. This research aims at understanding the fundamental principles at the molecular level for how cellular environments shape biological function and disease. Understanding how cellular environments alter biomolecular behavior will furthermore inform more effective rational design strategies to identify new therapies targeting a variety of diseases.